Behavioral and Social Science Research to Optimize SARS-CoV-2 Protective Vaccine Uptake in Racial Minority Communities with High Rates of COVID-19

ABSTRACT
Intensive efforts are underway to develop a vaccine protective against SARS-CoV-2 infection, and hope
is high that a safe and effective vaccine will soon be available. However, development of a vaccine does not
ensure its uptake on the scale needed to bring COVID-19 under control. In the United States, communities of
color are disproportionately burdened by COVID-19 diagnosis, serious illness, and death. However, experience
in areas such as influenza vaccination portends that COVID-19 vaccine uptake will be lower in African American
communities hard-hit by the disease. Racial disparities in influenza vaccination have been linked to individual
factors (including low vaccine awareness, medical mistrust, fears and vaccine skepticism); structural barriers
(such as not having an accessible primary health care provider); peer group norms that do not sufficiently
support getting vaccinated; and social, economic, and life stressors that contribute to many health inequities.
Similar but also unique factors are likely to undermine acceptance of COVID-19 vaccination in racial minority
communities. Community-engaged research must be undertaken now—and at a point before a vaccine is widely
available—to understand and address community concerns and to develop strategies to prevent racial
disparities in COVID-19 vaccination uptake. The planned research will be undertaken in Milwaukee by a team of
behavioral and social scientists in a collaboration with an established federally qualified community health center
serving low-income inner-city residents. The research will use mixed methods to identify minority community
concerns regarding COVID-19 vaccination; to determine factors that influence strength of community members’
intentions to vaccinate; and to pilot test and establish the feasibility and acceptability of a virtually-delivered
intervention that engages community social influencers to address vaccine concerns and endorse vaccine
benefits within their social networks. The work will be undertaken in an accelerated manner in three distinct but
interrelated phases, all with samples diverse in age and gender: (1) focus groups conducted with 160 African
American inner-city community members to elicit COVID-19 vaccine beliefs; perceived risks, benefits, and
norms; and factors that would impede or facilitate vaccination; (2) an online quantitative survey study that will
enroll 700 community members from zip codes with greatest SARS-CoV-2 rates and will measure respondents’
intentions to vaccinate and test the influence on those intentions of theory-based predictors including perceived
COVID-19 threat; perceived vaccination benefits, barriers, and self-efficacy, as well as identifying preferred
settings for vaccination; and (3) a feasibility and acceptability pilot test of a virtually-delivered intervention that
trains and enlists personally-known and trusted neighborhood social influencers to address the COVID-19
vaccination concerns of their friends, family members, neighbors, coworkers, and social media followers, and
that supports informed decisions about vaccination. This research will characterize vaccine concerns and identify
strategies that can optimize vaccine uptake in racial minority communities vulnerable to COVID-19.

Public health relevance
PROJECT NARRATIVE Intensive efforts are underway to develop a vaccine protective against SARS-CoV-2 infection, but development of a vaccine does not ensure its uptake in racial minority communities on the scale needed to reduce COVID- 19 disparities and bring the disease under control. This research will use mixed methods to identify concerns in the African American community about COVID-19 vaccination; to determine factors that influence the strength of community members’ intentions to vaccinate; and to pilot test and establish the feasibility and acceptability of a virtually-delivered intervention that engages personally-known and credible community social influencers to address vaccine concerns and endorse vaccine benefits within their social networks. The research will allow us to characterize community vaccine concerns and identify strategies to optimize vaccine uptake in minority populations disproportionately burdened by COVID-19.